High-throughput discovery platform for modulators of cardiac muscle proteins to treat heart failure

Project Summary
This Phase I SBIR collaboration between Photonic Pharma LLC (PP) and the University of Arizona (UA)
will establish proof-of-concept for an innovative drug-discovery campaign for treatment of heart failure (HF),
targeting cardiac myosin-binding protein C (MyBP-C). There is an urgent need for novel therapies for HF, a
major health problem affecting 1 in 30 adults in the US. MyBP-C has been identified as a therapeutic target for
correcting HF. Phosphorylation affects N-terminal MyBP-C structure, affecting its binding to actin and myosin,
modulating contraction and relaxation. Therefore, targeting MyBP-C with drugs that mimic phosphorylation
and/or modulate its binding to actin or myosin is a promising approach to treatment of heart failure. PP has
developed patented technology for fluorescent protein biosensors and high-throughput screening (HTS) based
on time-resolved fluorescence lifetime (FLT) detection, seeking breakthroughs in the early phase of drug
discovery with unprecedented quality, speed, and precision. UA brings expertise in MyBP-C and cardiac
muscle biophysics, biochemistry, and physiology. In a new publication, this collaborative team has identified
the first compounds that bind to MyBP-C and modulate its interaction with actin. The goal of this project is to
demonstrate proof-of-concept that drug targeting of MyBP-C is a powerful platform for discovery of novel
therapies to affect cardiac muscle protein function and ultimately patient outcomes in heart failure. Aim 1
studies will use a primary HTS assay of a 50,000-compound library of diverse and drug-like small molecules
(now justified by recently completed screens on a small validation library), using a novel FRET assay, to find
compounds that affect the interaction of MyBP-C-with actin. The fluorescence lifetime FRET (FLT-FRET)
assay uses site-specific fluorescent probes attached to actin and MyBP-C domains C0-C2. FLT measurements
provide a precise readout of protein binding and conformation. Small-molecule Hits will be evaluated to select
compounds with highest affinity interactions and/or sensitivity to phosphorylation. Aim 2 studies will use
secondary assays (lower throughput) to determine efficacy of Hit compounds on function. Selected compounds
will be evaluated by biochemical, biophysical, and physiological assays for effects on MyBP-C function, actin
binding, and contractility in cardiac cells. These novel screening strategies address the key missing aspect,
early-phase structure-based drug discovery, to enable MyBP-C therapeutic development, as needed to fine-
tune contractility and improve patient quality of life and survival. In Phase I we will validate the HTS assay for
application to commercial-scale drug screening. In Phase II we will enhance potency and specificity with
medicinal chemistry, evaluating the most promising compounds in increasingly physiological/pathological
conditions for the heart failure indication. Letters from major pharmaceutical companies indicate great
commercial potential for this technology, applied to this specific target and others. Our long-term goal: address
the unmet need for novel heart failure therapies that are commercially validated.

Public health relevance
Project Narrative Photonic Pharma LLC, in collaboration with the University of Arizona, proposes to establish proof-of-concept for an innovative drug-discovery campaign for treatment of heart failure, targeting cardiac myosin-binding protein C. This research addresses an urgent need for treatment of heart failure, which affects 1 in 30 adults in the US.